Easily Used Kits to Evolve Reagents that Covalently Tag and Inactivate Proteins

ABSTRACT
Under PAR-19-253, the NIGMS seeks new technologies that create a positive feedback loop that drives
science forward by allowing new questions to be asked and new discoveries to be made, which in turn drives
the development of new technologies. The Benner group has, for 30 years, contributed to this NIGMS vision,
developing new technologies for NextGen DNA sequencing and NextGen DNA synthesis, bioinformatic and
evolutionary analyses, dynamic combinatorial chemistry for drug discovery, protein engineering, and new
platforms that make multiplexed diagnostics easy, platforms used today to manage the COVID pandemic.
Here, we offer the NIGMS another transformative tool, a platform to allow researchers to choose a
protein target and create a reagent (an AEGISZyme) that chemically transforms bound proteins. Such
reagents have been sought for 40 years with only limited success.
We will focus on one transformation: AEGISZymes that add an acyl group to an amino group on a lysine of the
bound target, where the acylation reagent is an ester. This acylation may inactivate the targeted protein, allow-
ing researchers to test hypotheses about the role of that protein in biology. It may carry a payload which, when
internalized with the target protein, carry drugs or stabilized AEGISZymes into a cell. It may fluorescently tag
the protein to help clinicians cut away fluorescing cancer cells selectively as they resect a tumor.
To achieve this transformative and innovative outcome, we will apply laboratory in vitro evolution (LIVE) to
artificially expanded genetic information systems (AEGIS). The platform will be delivered by meeting 3 Aims:
Aim 1. We will use AEGIS-LIVE to deliver AEGISZymes that acylate lysines in target proteins with pass/fail
reaction times of <10 sec-1. To test this, we will create these AEGISZymes that use a co-substrate carrying an
ester group for three targets. Rates of the selected AEGISZymes will be quantitated, specificity will be metricked
against similar targets with slightly different amino acid sequences, and modification sites will be found,
Aim 2. We will use AEGIS-LIVE to deliver AEGISZymes that acylate lysines on researcher-chosen targets with
turnover, with pass/fail turnovers of >1000 and kcat/KM of >105 M-1 sec-1. Turnover rates will be metricked
under physiological and laboratory conditions, and correlated to duplex stability from thermodynamic data.
Aim 3. We will use AEGIS-LIVE to deliver mirror AEGISZymes that are stable in biological systems, including
transport into cells. This will allow AEGISZymes to be used in biological media, to support nanotrain toxin
delivery, and to set the stage to use these molecules in vivo.
Aim 4. We will test the scope of the platform to address design parameters, such as how long random regions
should be, how good loops are as full protein surrogates, and how sequence space is searched.
Last, to lay to rest any view that AEGIS-LIVE is too "cumbersome", we will create distributable kits that allow
their recipients to make their own AEGISZymes. This is the ultimate in authentication and reproducibility.

Public health relevance
NARRATIVE The NIGMS has asked for plans to create new tools and technologies that will allow researchers to ask new questions, questions that they might not even think of asking without these tools. We provide such a plan here, to deliver a technology platform that will create molecules that covalently modify, tag, and destroy protein targets that are chosen by researchers and clinicians to solve scientific, diagnostics, and disease management problem. This platform has been sought without success for over 40 years, because it can be applied to every area of medical research, diagnostics, and disease treatment. As just four examples, modification may attach a payload to the protein, allowing it to be internalized to cancer cells. It may fluorescently tag cancer cells to guide a surgeon cutting out a tumor. Its tagging capabilities will help neurobiologists map the brain. For researchers, modifying the targeted protein, researchers will test hypotheses about the role of that protein in biology, both natural and diseased.